Core C: BBC: Biostats and Bioinformatics Core

PROJECT SUMMARY – BIOSTATISTICS/BIOINFORMATICS CORE
The Biostatistics/Bioinformatics Core of the Hillman Cancer Center (HCC) Ovarian Cancer (OvCa) SPORE
provides services for the design of experiments and the analysis of in vitro, in vivo, clinical, translational and -
omics data. The investigators and staff of both segments of the Core have significant experience in research in
ovarian cancers, so that data are analyzed in the appropriate scientific context, increasing the Core's efficiency
and effectiveness compared to general purpose data analysis services. Biostatistics and Bioinformatics
combines classic statistical techniques with contemporary Bayesian, machine learning and genomics methods
to ensure that every research project, Developmental Research Program and Career Development Program
awardee in the SPORE has access to the most appropriate analyses. The Core will also work closely with the
Administrative Core and the Translational Pathology Core to ensure that data flows between laboratories,
clinics and analysts are efficient and that data and resource sharing can be effective and comprehensive.
The BBC Co-Directors are Dr. Curtis Tatsuoka (Biostatistics) and Dr. Riyue Bao (Bioinformatics) who have
assembled an excellent team to help achieve the goals of the OvCa SPORE.

Public health relevance
PROJECT NARRATIVE – BIOSTATISTICS/BIOINFORMATICS CORE The Biostatistics/Bioinformatics Core provides specialized analysis services to the clinical, laboratory, translational and “-omics” research projects of the Hillman Cancer Center Ovarian Cancer SPORE to ensure that experiments are efficiently designed and data are analyzed in a rigorous and reproducible fashion by analysts familiar with cancer in general and ovarian cancer in particular.